Rapid Synthesis of Topologically Complex Molecules with Tungsten Dearomatization Agents

Project Summary/Abstract
The development of a new pharmaceutical agent often requires the screening of millions of compounds. Such
compounds are typically derived from high-throughput syntheses, which tend to utilize a relatively small set of
reliable reactions. The limited scope of synthetic methods used in discovery chemistry has led to an
overpopulation of certain types of molecular shapes and properties, to the exclusion of others. The challenge is
to generate new classes of compounds with both diversity and complexity in a manner that is accessible to
medicinal chemists. Such methodologies would open new, more prolific chemical space for exploration in both
traditional SAR studies and the generation of fragment libraries. Research in the Harman group concentrates on
the preparation of stereochemically complex alicyclic compounds derived from simple aromatic precursors.
While previous studies from our group have included dearomatization of pyridine, furan, and pyrrole
heterocycles, this MIRA application describes the preparation of functionalized cyclohexenes from benzene. The
otherwise inert benzene ring is chemically enabled through its dihapto-coordination to the tungsten complexing
agent {WTp(NO)(PMe3)}. Over the next five years we will explore the full range of nucleophilic and electrophilic
fragments that can be added to a benzene core, as enabled by this tungsten complex. Specifically, we describe
in this application the development of a general route to the addition of so-called "π-nucleophiles", such as
phenols, anisoles, furans, thiophenes, and indoles, generating new sp3 stereocenters from the benzene ring
carbons. Further, we are targeting the addition of more complex nitrogen-based functional groups including
amides, imides, sulfonamides, uracils, carbazoles, and triazoles. Significantly, these nitrogen additions to the
benzene ring that create new stereocenters are practically unknown. Another research thrust in the next five
years will be to surgically manipulate the regiochemistry and stereochemistry of the cyclohexene targets,
developing general routes to 3,4- 3,5- and 3,6- disubstituted cyclohexenes with either cis- or trans-
configurations. A third major thrust will be the assembly of polycyclic cores with well-defined stereochemistry.
Using the foundations that we have developed, we are pursuing several different approaches to structurally
complex and biorelevant tri- and tetracyclic lactams and lactones. The ultimate goal of our program is to provide
access to a broad and diverse class of enantioenriched organic cyclohexenes and cyclohexanes, all prepared
from a single, logical, and highly modular platform. This dearomatization methodology will open more fertile
chemical space-- fragment libraries that feature a diverse range of complex three-dimensional architectures with
many of the functional groups common to proven pharmaceuticals. This approach not only increases the
chances for finding new lead-like compounds for pharmaceutical development with increased affinity for a
targeted binding site, but more importantly, increased specificity for that site.

Public health relevance
Project Narrative The goal of the described research program is to develop new classes of chemical compounds to be screened for efficacy against various diseases. The synthetic approach described in this proposal, which involves a tungsten-activated benzene substrate, is fundamentally different than other known approaches to cyclohexene and cyclohexane compounds, and allows access to new materials with widely diverse shapes that are rich in amines, amides, carboxylic acids, esters, and heterocyclic fragments groups that are ubiquitous in pharmaceutical agents. Access to such compounds improves the chances for the discovery and development of new medicines to improve public health.